Identifying targeting antibodies in an in vitro model of the human blood-brain barrier during ischemic stroke

Stroke is one of the leading causes of disability and death in the US. One of the contributing factors to this
is the lack of FDA approved treatments for chronic stroke. Aside from tissue plasminogen activator (tPA),
there are no other approved therapeutics with disease modifying effects; current therapy is entirely focused
on symptom management and rehabilitation. This is in part due to the lack of understanding of the
underlying mechanisms involved, as well as the difficulty of delivering therapeutics through the blood-brain
barrier (BBB) and into the brain. This project aims to address both of these difficulties through the
development of a human induced pluripotent stem cell (hiPSC) derived model of the BBB incorporating
hiPSC derived brain microvascular endothelial like cells (BMECs), astrocytes, and neurons. Using a 3D
microvessel platform ischemia will be modeled using perturbations in shear flow, oxygen concentration,
and nutrient availability. The resultant phenotype of the cells will be investigated using live cell microscopy
to measure permeability of fluorescent tracer molecules, as well as morphological changes in the cells.
Using this model, as well as a simplified 2D model of ischemia, a library of antibodies will be screened for
improved targeting and delivery to the human ischemic brain. Finally, the antibodies identified in the screen
will be tested for efficacy in delivering known non-brain penetrant neuroprotectant growth factors to the
ischemic brain both in the in vitro model and in a mouse model of stroke. In summary, this project will
establish a human specific model of the BBB during ischemic stroke and identify antibodies that are able to
specifically target and deliver therapeutics to the ischemic region of the brain.

Public health relevance
This project will establish a human specific model of the blood-brain barrier in stroke, allowing for increased understanding of how brain vasculature responds to an ischemic stroke. It will also result in the identification of antibodies that target the ischemic brain for improved efficiency of drug delivery.